Kindlin-3 signaling in neutrophils

PROJECT SUMMARY/ABSTRACT
Inflammation plays a pivotal role in the rapid removal of harmful stimuli, either sterile or infectious; however,
uncontrolled inflammation can lead to a variety of chronic inflammatory disorders. Neutrophils constitute the
front line of the innate immune response, and swiftly undergo a carefully choreographed process to locate and
destroy potentially pathological threats. Neutrophil recruitment is an integrin-dependent, chemotaxis-directed
process that is followed by production of reactive oxygen species (ROS) and release of neutrophil extracellular
traps (NETs), together which serve to remove or kill the offending agents. To minimize collateral damage to
host tissues, however, the killing functions of neutrophils must be carefully regulated in both a temporally and
spatially controlled manner; the mechanisms at play to regulate neutrophil activation, however, remain poorly
understood. Kindlin-3, an integrin β cytoplasmic domain binding partner, and an essential integrin activator in
cells of hematopoietic origin, is known to play an important role in promoting integrin-mediated neutrophil
recruitment to the sites of inflammation. Paradoxically, however, we have recently discovered that neutrophil
kindlin-3 also acts to suppress ROS production and NET release in an integrin-binding independent manner.
Thus, kindlin-3 in neutrophils possesses both pro- and anti-inflammatory properties, indicating that it may
function as a bifunctional modulator of neutrophil activation. Interestingly, our preliminary studies have
revealed that neutrophil kindlin-3 unexpectedly becomes degraded upon inflammatory challenges. Based on
these findings, we propose that degradation of neutrophil kindlin-3 is a key step in the cellular decision tree
regulating neutrophil activation under inflammatory conditions. The purpose of this application, therefore, is to
explore novel, heretofore unexplored mechanisms regulating kindlin-3 degradation and to examine its
functional significance in inflammatory responses. Two Specific Aims are proposed. In Specific Aim 1, we will
determine the mechanism by which kindlin-3 undergoes degradation in stimulated neutrophils, including both
human and mouse neutrophils. In Specific Aim 2, we will determine the functional significance of kindlin-3
degradation in neutrophils in response to inflammatory challenges, such as under pathological conditions of
endotoxemia and acute lung injury. These timely and complementary studies will establish an important and
novel role for kindlin-3 in neutrophils in modulating inflammatory responses. Findings made will fill important
gaps in our understanding of neutrophil biology, and may lead to novel opportunities for developing more
specific and safer anti-inflammatory strategies for treating complications in a whole host of inflammatory
diseases, including the recently described inflammatory complications present in COVID-19.

Public health relevance
PROJECT NARRATIVE The goal of this research project is to produce mechanistic insights into kindlin-3 signaling in neutrophils, and provide opportunities for developing more specific and safer anti-inflammatory strategies for treating complications in a whole host of inflammatory diseases, including the recently described inflammatory complications present in COVID-19.